Novel therapeutics development and mechanisms of therapeutic resistance in gastrointestinal stromal tumor (GIST)

RP-1: Novel Therapeutics Development and Mechanisms of Therapeutic Resistance in GIST
ABSTRACT
Gastrointestinal stromal tumor (GIST) represents one of the most prevalent sarcoma subtypes and is
the most common mesenchymal neoplasm of the GI tract. Most GISTs harbor activating oncogenic
“driver” mutations in receptor tyrosine kinases, e.g. KIT or PDGFRA. Among KIT/PDGFRA wild-type
GISTs, the majority harbor loss-of-function defects in the mitochondrial succinate dehydrogenase
(SDH) complex, a component of the Krebs cycle. KIT/PDGFRA-mutant and SDH-deficient GISTs
represent molecularly distinct groups, with distinct clinical behaviors. We have recently identified
ETV1 as a master regulator for the lineage specification and normal development of the GIST precursor
cells, the interstitial cells of Cajal. Importantly, ETV1 is required for the growth and survival of
imatinib-sensitive and -resistant GISTs in vitro and for tumor initiation and maintenance in vivo. We
hypothesize ETV1 is a novel therapeutic target that is critical for the shared lineage-dependent survival
of both imatinib-sensitive and -resistant GISTs. In this project, we propose a comprehensive study to
understand the regulation of ETV1 protein stability, and to develop novel therapeutic strategies
targeting ETV1 protein stability using various pre-clinical GIST models. In parallel, we will investigate
clinical samples from prior and ongoing clinical trials designed to target ETV1 protein stability to better
understand the molecular mechanisms of therapeutic resistance. Moreover, targeted sequencing using
custom IMPACT panels will be used on these matched pre- and post-therapy biopsy samples from the
on-going phase Ib/II trials using imatinib in combination with MEK162 to elucidate mechanism of
drug resistance. This investigation will leverage comprehensive and multidisciplinary approaches,
including biochemical, state-of-the-art genomics, and genetic approaches in in vitro and in vivo models
as well as patient tumor samples derived from current GIST clinical trials. The therapeutic strategies
identified here may benefit other ETV1-dependent malignancies. Lastly, since there are no in vitro and
in vivo models for focused mechanistic and therapeutic investigation of SDH-deficient GISTs, we will
generate cell line models through novel gene editing technology, such as CRISPR and CRISPRi, in
established GIST cell lines as well as in human mesenchymal progenitor cells that are committed to the
interstitial cells of Cajal lineage. We will also develop in vivo murine models of SDH-deficient GISTs for
focused evaluation of therapeutics specifically targeting SDH deficiency that may benefit other SDH-
deficient malignancies beyond GIST.

Public health relevance
RP-1: Novel Therapeutics Development and Mechanisms of Therapeutic Resistance in GIST NARRATIVE Gastrointestinal stromal tumor (GIST), a common subtype of soft tissue sarcoma, is difficult to manage because most tumors eventually develop resistance to imatinib, the best available drug. We have identified a protein called ETV1 as a novel therapeutic target in both imatinib-sensitive and imatinib- resistant GIST. Here, we propose comprehensive, collaborative and multidisciplinary studies to better understand the mechanisms of ETV1 biology and therapeutic targeting of ETV1 in GIST as well as developing model systems for investigating a poorly understood GIST subtype (SDH-deficient GIST), with the goal of expedited development of novel therapeutics that will benefit the majority of patients with advanced GIST.